Huntington's Disease: Learning from Extremes

Huntington’s disease: Learning from Extremes

Abstract: Huntington's disease (HD) is a fatal genetic neurodegenerative disorder characterized by progressive
motor, psychiatric and cognitive decline. It is caused by a genetic mutation leading to the global cellular
expression of the mutant huntingtin protein (mtHtt), which is particularly toxic to the CNS. Disease modifying
treatments are not yet available for this devastating and lethal disease. One of the challenges for designing
efficient clinical trials is the tremendous clinical variability that is observed. Much of that variability is contained
in the markedly different rates of progression between subjects, which are likely caused by both genetic and
environmental factors. Variable progression is not explained by the CAG expansion length since the vast majority
of individuals with HD fall in a limited range of CAG lengths spanning 41-­47 yet have ages of clinical onset from
childhood to the 8th decade of life. Genome-­wide association studies (GWAS) have uncovered some potential
and very limited contributions from other genes and do not explain the extremes observed clinically. We have
studied non-­juvenile HD subjects matched for CAGn and disease duration and having early and late onset and
find that earlier onset is associated with more rapid cerebral atrophy and older onset with slower cerebral atrophy,
suggesting that age-­of-­onset is a strong predictor of the slope of progression. Understanding the biological
factors that underlie divergent ages of onset and rates of progression may uncover correlates that enable
understanding and predicting rates of progression and may help identify new treatment targets. We have
previously identified altered metabolomic, genetic, and transcriptomic markers from the blood and in HD subjects
that represent pathways that could influence progression. We propose to expand our cohort of early and late
onset subjects, evaluate their progression clinically and by neuroimaging, and to perform both unbiased and
targeted studies of blood and csf markers to seek distinguishing clues to the variance in progression.

Public health relevance
Project Narrative Huntington Disease (HD) is a devastating, fatal, and so far untreatable neurodegenerative disease with considerable variability between patients. We have observed that earlier onset is associated with more rapid brain atrophy and older onset with slower atrophy, suggesting that age- of- onset strongly predicts the rate of progression. We propose to study young and old onset subjects using advanced neuroimaging methods, and to seek genetic and molecular clues in their blood that could help explain the different ages of onset and rates of progression in human HD and suggest new treatments and biomarkers.